Administrative Core

Project Summary: Administrative Core
This BRAIN Initiative proposal Oxytocin Modulation of Neural Circuit Function and Behavior is located at NYU Grossman School of Medicine, and each of the four Project team labs (Tsien, Buzsaki, Lin, and Froemke) are housed within the Neuroscience Institute at NYU Langone Health, in proximity to the five Cores (Administrative, Behavior, Computational Modeling, Data Science, and Molecular Tools). The first five years of this effort was considerably productive and transformative here at NYU, leading to a number of collaborative publications and set the groundwork for this new proposal. Our team studies and activites will therefore benefit from integration with the larger NYU scientific environment, including the Neuroscience graduate program, an existing and robust scientific outreach program, a strong history of activities supporting mentoring and broad access to research, and institutional resources including a cutting-edge health science library and data management system and a strong administrative staff.
This Administrative Core will help ensure the management, coordination, and interactions between these components of this proposal. Aim 1 of the Administrative Core is to continue to enable productive and synergistic interactions between Project team labs, coordinating with the Internal and External Advisory Committees, and scheduling regular meetings for open communication, sharing of scientific results, developing collaborations, and providing opportunities for trainee engagement. Aim 2, under the direction of Dr. Froemke as mentorship champion, is to enhance the scientific training and careers of junior colleagues in team labs, including graduate students, postdoctoral fellows, and technicians, by facilitating co-advising and interactions with NYU training programs. We will also develop activities that support broad access to research for trainees and staff from all backgrounds. Aim 3 is to ensure that our results are clearly communicated in a timely manner to NIH staff, other scientists, and the public. Our labs are committed to data sharing, and we will continue to work with the Data Science Core on these efforts. The Neuroscience Outreach Group at NYU has substantial connections with schools and museums throughout New York City, and engages in activities both at the city and national level (particularly through the Society for Neuroscience). Finally, Aim 4 will ensure the appropriate management of Project and Core finances and the overall budget. Administrative Core Co-Directors and staff members are highly experienced at managing multi-PI projects and budgets. Drs. Tsien, McKellar, and Froemke, bring complimentary expertise and a solid working relationship to their leadership roles within the Administrative Core. They will continue to enable synergistic and accelerated scientific progress across team labs, support career development of trainees and foster a collaborative community, and effectively communicate our findings to the greater scientific and public communities.